The Role of c-ABL in Mediating TIE2 Signaling and Formation of Venous Malformation

PROJECT SUMMARY/ABSTRACT
Venous malformations (VMs) are vascular lesions with abnormally enlarged vessels that are disfiguring, painful,
and have complications such as bleeding and thrombosis. Current therapeutic options are not universally
effective, can require life-long treatment, and fail to produce full lesion regression, indicating that investigation of
novel causative pathways is needed. VM is associated with mutation in the endothelial tyrosine kinase receptor
TIE2, the most common of which is the p.L914F mutation. However, studies into the cellular mechanisms driving
VM pathogenesis are hindered by the lack of an in vivo model of TIE2 mutation. In addition, our lab has recently
shown that c-ABL, an intracellular tyrosine kinase, is activated in endothelial cells (EC) upon ligand stimulation
of TIE2 or with expression of mutant TIE2 p.L914F. Furthermore, we have also observed that ABL inhibition
mutually reduces TIE2 activation by an unknown mechanism. To address these questions, my proposal rests
on a central hypothesis: increased c-ABL signaling downstream of hyperactive mutant TIE2 p.L914F in
endothelial cells promotes formation of venous malformation through feed forward TIE2/c-ABL
signaling. We will address this hypothesis through the following Specific Aims: 1) define the effects of c-ABL on
TIE2 activation and signaling and 2) determine if c-ABL is required for formation of VM lesions in vivo. In this
work, we will define how ABL signaling affects physiological and pathological TIE2 activation in endothelial cells
utilizing in vitro functional assays and both loss of function and gain of function of c-ABL. We will also utilize our
newly developed transgenic mouse model of TIE2 L914F-driven VM to investigate the cellular defects associated
with VM pathogenesis. This model will then be used to investigate the role of c-ABL in VM formation in vivo and
provide preclinical testing of ABL inhibition for the treatment of VM. The information obtained from this project
will elucidate the relationship between TIE2 and c-ABL signaling in physiological and pathological vascular
function and will establish the first genetic mouse model of mutant TIE2-driven VM, which will be essential for
further study of the mechanisms of VM pathogenesis.

Public health relevance
PROJECT NARRATIVE Venous malformation (VM) is a disease in which patients are affected by enlarged and abnormal veins that cause pain, disfigurement, and other severe complications. This study will use a novel mouse model of VM to investigate how TIE2, a protein that is often mutated in VM patients, and c-ABL, a protein that is involved in TIE2 signaling, play a role in formation of VM. In doing so, this project will increase our understanding of the mechanisms that drive VM formation and will investigate the therapeutic potential of targeting c-ABL to treat VM patients.